Oral Microbiome Dysregulation as a Contributor to Depressive Symptoms and Altered Brain Connectivity in a High-Risk Sample of Youth

Project Summary/Abstract
Depressive symptoms represent a serious challenge to youth mental health. There is therefore an
urgent need for the identification of possible mechanisms underlying risk for youth depressive
symptoms. This is especially crucial for certain high-risk populations, such as youth with a history
of adversity exposure. Dysregulation of the oral microbiome, the community of microorganisms
inhabiting the human oral cavity, may function as a mechanism underlying risk for depressive
symptoms in youth. The oral microbiome is a compelling putative mechanism for youth depressive
symptoms because it is manipulable via non-invasive interventions, such as probiotic
supplementation, while, at the same time, remarkably resilient to insults once it has stabilized in
early adulthood. Indeed, oral microbiome dysregulation has been linked to depressive symptoms,
experimentally in animal models and observationally in human youth. However, in order for
potential mechanisms underlying this link to be elucidated, there is a need for research that
examines the oral microbiome and depressive symptoms longitudinally, that examines the
microbiome at a functional level, and that incorporates neuroimaging to better understand
depressive symptom etiology. The current project will address these gaps by leveraging a 3-year
longitudinal study of youth, ages 6-16 at the first timepoint (N=152), with the first 2 timepoints
completed and the 3rd underway. This project oversamples for adversity-exposed youth (N=66), a
population at increased risk of both depressive symptoms and oral microbiome dysregulation. Oral
microbiome composition and depressive symptoms will have been assessed at all three
timepoints, and functional Magnetic Resonance Imaging (fMRI) conducted at the final timepoint.
We will analyze the relationship between the oral microbiome and depressive symptoms, and the
relationship between the oral microbiome and functional brain connectivity. We hypothesize that
elevated pathogenic taxa, increased pro-inflammatory functions of the oral microbiome, and
decreased aromatic amino acid precursor biosynthesis will be associated with increased
depressive symptoms. We further hypothesize these same indicators of oral microbiome
dysregulation will also be associated with altered functional brain connectivity, especially within the
affective limbic network, reward network, default mode network, and cognitive control network. This
project’s findings will yield critical understanding about potential peripheral mechanisms underlying
depressive symptoms in both typically developing and high-risk youth.

Public health relevance
Project Narrative Depressive symptoms in youth represent an urgent public health concern, the amelioration of which necessitates the identification of intervenable mechanisms that underly this risk. This project examines the role of the oral microbiome, the community of microorganisms inhabiting the human oral cavity, as a potential mechanism underlying youth depressive symptom risk. By leveraging a longitudinal design, functional microbiome sequencing, and neuroimaging data, this project will provide yield critical information that can ultimately inform treatments or preventions for youth depressive symptoms.